Elucidating the role of jails in MRSA community transmission

Project Summary
Methicillin-resistant Staphylococcus aureus is a serious threat according to the Centers for Disease
Control and Prevention (CDC), due to the increased morbidity and mortality among individuals who are infected
with this pathogen.1 As a common healthcare- and community-associated pathogen, MRSA has a high burden
of disease with over 300,000 cases and roughly 11,000 deaths in 2017.1 Though the overall rates of MRSA
infection have been decreasing nationwide, this has not translated in communities of color, as the rates of
healthcare-associated (HA), healthcare-associated community onset (HACO), and community-acquired (CA)
MRSA is much higher among blacks compared to white individuals. 2–6In addition, we understand that jails have
a disproportionately high prevalence rate of MRSA (19%) and a high proportion of people of color.7,8 Detainees
have high rates of recidivism with about 76.6% of prisoners are rearrested within five years. 8 Once released,
detainees interact with the community they came from prior entering the jail, resulting in potential transmission
events. What is not well-understood is if jails themselves are an amplifier of MRSA community transmission.
In this proposal, we will investigate the relationship between jail transmission of MRSA and the potential
of transmission spillover into the wider community by utilizing genomic-based regression approaches and
individual-based modelling. The results will elucidate how can jails amplify community transmission, especially
among communities of color, and may perpetuate high rates of MRSA infections and/or colonization.
Understanding this phenomenon will allow us to improve MRSA surveillance in these communities and design
and increase targeted interventions in communities of color and within jails that potentially feed into their
communities.

Public health relevance
Project Narrative Congregate settings and communities of color have been shown to have higher rates of methicillin-resistant Staphylococcus aureus. Understanding the role places like jails play in community transmission of MRSA, could provide insights into community transmission, and provide the possibility of improving surveillance within the community and interventions within the jail. Using a modeling approach that considers closely related genomes, this proposal aims to determine the factors (i.e., individual, and community-level factors) that are associated with jail MRSA transmission and whether jail amplifies the transmission of MRSA within the community.